TWO DOSES OF 2,3'DDI IN CHILDREN WITH HIV EITHER RESPONSIVE OR INTOLERANT TO ZDV

Study objectives are to evaluate the long term (48 weeks) safety, tolerance and efficacy of DDI at 50 mg/m2 taken orally every 12 hours in children w/symptomatic HIV infection who have developed toxicity during prolonged zidovudine therapy or who have demonstrated disease progression after 6 months of ZDV therapy.